Connecting PanKbase knowledge graph with Proto-OKN

Abstract
PanKbase, standing for the diabetes Pancreas Knowledgebase program, is a new foundation data science
program started Feb 1, 2024. It is designed to have 5 components: database, software system, open science
platform, partners, and community participation. Under the software system, it plans to develop PanKGraph, a
knowledge graph component. In this supplement, we will provide PanKGraph to the landing zones of the
Fabric projects for ingestion into the NSF Proto-OKN.

Public health relevance
Narrative The overall goal of this project is to develop PanKbase, a centralized and comprehensive resource of the human pancreas for the diabetes research community, with a focus on type 1 diabetes (T1D) pathogenesis. If successful, results from this project will provide new insights into T1D pathogenesis and enable the development of new therapies and biomarkers. The project will also foster cross-disciplinary collaborations and promote innovation, with the ultimate aim of improving the lives of people with T1D.